FAMU Center for Health Disparities Research

FAMU Center for Health Disparities Research
OVERALL SUMMARY
The overarching goal of the Florida A&M University (FAMU) RCMI Center application (2019-2024) is to
establish an interdisciplinary Center to address minority health and health disparities while building on
and enhancing the competitiveness of faculty-led health disparities research to attract extramural
funding. Our Center for Health Disparities Research will enhance basic biomedical and behavioral
research at FAMU while also improving upon investigator's research skills. To achieve the goal of the
Center, we are proposing the following specific aims: 1) Enhance FAMU research capacity and
rigor for basic biomedical/behavioral research pursuits by supporting innovative research projects,
expanding research infrastructure, and strengthing community engagement partnership and activities
that will create a sustainable research environment. 2) Increase the success rate of FAMU
investigators in obtaining extramural research funding by enabling investigators to develop cutting-
edge research competencies through the offering of Career Enhancement Program (CEP), the use of
innovative technology, collaborations and use of resources provided by the RCMI Research
Coordination network (RRCN). 3) Support new faculty and early career investigators in health
disparities research by establishing an Investigator Development Core that will provide pilot projects
funding and a robust mentoring program accompanied by a platform through the Career Enhancement
Program. 4) Establish and support partnerships with the community to create a sustainable
research environment that addresses health disparities research by establishing the RCMI Community
Engagement Core (CEC) to promote early education awareness, detection, and screening. The center
will also support three Innovative research projects in the areas of basic biomedical and behavioral
addressing mechanisms, and screening intervention to reduce health disparities among minorities.
These research projects will address novel therapy in breast cancer, validate innovative drug delivery
for lung cancer and investigate new approaches to promoting colorectal cancer screening among
minorities. Also, the Center will establish well-engaged collaborations and partnerships with recognized
research centers and leverage the resources provided by NIH-supported programs such as the RCMI
Research Coordination Network (RRCN) and NRMN. Achieving the goals of the Center will be greatly
facilitated by the commitment and partnership of the Mayo Clinic Comprehensive Cancer Center-
Jacksonville Florida, with its SPORE grants which will provide an environment that is conducive to
career enhancement that would increase minority Junior Investigators' professional development and
retention in cancer research. Also, the excellent opportunity of collaboration between the NCI U54
Funded Florida-California (CARE2) Health Equity Center and FAMU RCMI Center will provide many
avenues to enhance and ensuring achieving the goals of the FAMU RCMI Center. The Center will have
an external independent evaluator to implement an evaluation plan to reach data-driven decisions that
will optimize the efficiency, effectiveness, and success of the center. The funding of this RCMI Center
will enable FAMU achieving its mission of addressing health disparities through the enhancement of
FAMU research capacity, increasing the number minority research investigators and promoting minority
health and aid in the reduction of minority health disparities.

Public health relevance
Public Health Impact: Florida A&M University is proposing to establish the RCMI Center in collaboration and partnerships with community- based organizations to address minority health and health disparities research. The center will enhance FAMU's research capacity, increase the number of minority research investigators, promote minority health, and aid in the reduction of health disparities.